B Cell Renaissance: Epigenetics, Regulation and Immunotherapy

ABSTRACT Support is requested for a Keystone Symposia conference entitled B Cell Renaissance: Epigenetics, Regulation and Immunotherapy, organized by Drs. Paolo Casali, Nicole Baumgarth, Meinrad Busslinger and Elizabeth Leadbetter. The conference will be held in Banff, Alberta Canada from March 1-5, 2019. This conference will bring together experts in B cell biology to discuss the most recent advances in B cell research from initial development, through maturation, including effector or memory development, until terminal differentiation. The results of these recent B cells studies are guiding researchers to become more appreciative of the importance of the molecular changes, including epigenetic marks, modifications and factors that control and modulate B cell development and differentiation as well as the regulatory forces which influence functional paths of B cells. The complexities of B cell differentiation pathways through germinal centers and extra- follicular foci in primary lymphoid organs, in addition to novel interactions in diverse secondary lymphoid tissues, are also under intense study in both mice and humans. The interactions of B cells with lymphoid cells, non-lymphoid cells, and secreted factors in a myriad of environments will be covered in conference sessions. This will help elucidate the numerous factors which influence and ultimately dictate the contribution of each unique B cell subset to homeostasis, immune defense or immunopathology. Understanding the drivers which influence B cell differentiation and function will enable precise harnessing of these key elements to optimize the immuno-therapeutic effect of B cells and their antibodies in autoimmune disease, infection, and cancer.

Public health relevance
PROJECT NARRATIVE B cells are lymphocytes involved in antigen-specific immune defense by generating antibodies that can destroy invading pathogens and suppress tumor growth; they also regulate and enhance the functions of the innate immune system. The new ideas and collaborations established at this conference will lay critical foundations for developing new translational strategies for targeting human autoimmune diseases in the future. Outcomes from this conference will also drive advances in areas outside immunology, including epigenetics, gene and cell regulation, imaging, metabolism, and immunotherapies for cancer and infectious diseases.